Neural circuit elements that orchestrate cue-reward associations

Project Summary: The neural circuitry that encodes and mediates the establishment of cue-reward associations, an adaptive process that is essential for survival, likely becomes dysfunctional in neuropsychiatric illnesses such as drug addiction. While the full encoding of cue-reward associations require a distributed network of brain nuclei acting in concert to orchestrate behavioral output, neurons in ventral tegmental area and upstream circuits in cortex and hypothalamus are thought to play an important role in reward prediction and assigning incentive salience to environmental cues such as those that become associated with repeated drug use. In this application, we propose to state of the art deep brain two-photon imaging in awake and behaving mice to study how the encoding properties within these circuits emerge and are altered during primary reward exposure as well in associative learning. These experiments will provide important mechanistic information to explain how reward circuits encode and control the development and expression of cue-reward associations relevant to addiction.

Public health relevance
Project Narrative (Public Health Relevance Statement): Psychiatric and neurological diseases and disorders have a tremendous impact on society. Despite improved diagnosis and treatment, further advancement is significantly hindered by a lack of understanding how alterations in neural circuit function leads to the development and expression of disease states. The research directions outlined in this proposal will characterize the function of key neural circuits that are involved in psychiatric disease such as substance abuse disorders. We aim to study these neural circuit elements in order to identify potentially novel therapeutic targets for the treatment neuropsychiatric disorders.